Mentoring alcohol use intervention research in HIV health care settings

Project Summary/Abstract
Unhealthy alcohol use plays a major role in risk for and exacerbation of HIV/AIDS. There is an urgent need to
implement effective alcohol intervention strategies, train new researchers, and reduce ongoing health
disparities in order to end the HIV epidemic. Addressing these critical issues, this K24 renewal application
proposes to extend the mentoring program in patient-oriented research (POR) of Dr. Derek Satre, Professor in
the University of California, San Francisco (UCSF), Department of Psychiatry and Behavioral Sciences, and
Adjunct Investigator in the Kaiser Permanente Northern California Division of Research (DOR). Dr. Satre’s
research program is focused on alcohol interventions in the context of HIV care, including serious
comorbidities such other substance use, mental health problems, and medical conditions. In the current K24
cycle, Dr. Satre has met and exceeded the aims of the award and been highly productive: he has published 75
papers (36 with mentees as first author) and obtained two R01s in HIV and alcohol research based in health
systems. His mentees are primarily clinicians and they have been very successful in their research careers,
including two K awards with Dr. Satre as primary mentor, and many other mentees have received NIH grants
and faculty positions. This renewal will enhance Dr. Satre’s ability to develop, and implement effective alcohol
interventions with people with HIV (PWH) especially racial/ethnic minorities, who are disproportionately
impacted. His mentoring will continue to be based in alcohol and HIV health settings and outstanding training
programs. New in this renewal, he proposes to develop an innovative alcohol POR mentoring program within
the UCSF Center for AIDS Prevention Studies (CAPS) Visiting Professor Program, to enhance the careers of
underrepresented minority junior scientists. Mentees will leverage the infrastructure and resources of Dr.
Satre’s ongoing studies, which include large alcohol and HIV data sets and multidisciplinary research
collaborators. Dr. Satre proposes to further enhance his clinical POR mentoring by obtaining training in
implementation science and social determinants of health. The proposed research to be conducted with
mentees extends his recently funded R01 to examine alcohol risk profiles, access to alcohol treatment and HIV
clinical outcomes, to inform alcohol intervention implementation. In summary, this K24 renewal will leverage
Dr. Satre’s research mentoring program with extensive infrastructure at UCSF and DOR to support a program
of expanded POR mentoring in alcohol and HIV intervention research, to advance the goal of implementing
effective interventions to reduce alcohol-related problems for PWH.

Public health relevance
Project Narrative Unhealthy alcohol use adversely impacts HIV care and is associated with multiple physical and mental health comorbidities, and racial and ethnic minorities are disproportionately affected. There is an urgent need to train new scientists in patient-oriented research, address disparities, and implement alcohol interventions in HIV care. This K24 renewal application extends a highly productive and successful research mentoring program to increase opportunities for mentees in these critical areas, and proposes new HIV and alcohol mentoring opportunities for diverse clinicians and junior scientists, especially for those from racial and ethnic minority groups under-represented in medicine.